The Alama Project: Autism outcomes and neurobehavioral markers in young children born to mothers with HIV in Kenya

PROJECT SUMMARY
An estimated 14.8 million children – 90% of whom live in Africa – are HIV-exposed and uninfected (CHEU).
Despite advances in understanding health outcomes of CHEU, the neurodevelopmental impact of HIV exposure
has not been well characterized. Several small studies conducted in high income countries (HIC) suggest a
higher prevalence of autism in CHEU. CHEU may be at elevated risk for autism due to HIV exposures, which
are associated with adverse birth outcomes, iron-deficiency anemia, and maternal and child infectious morbidity.
These risks have been shown to be associated with autism outcome in HIC, but no study to date has examined
autism in CHEU in Africa where the vast majority of these children live. Investigating autism in CHEU has high
potential to identify mediating risks on the causal pathway between HIV exposure and autism outcome and
inform the selection of modifiable targets for precision detection and intervention strategies in low- and middle-
income countries (LMIC). However, there is a lack of neurodevelopmental expertise and tools to carry out
research in these settings. Scalable diagnostic and neurobehavioral tools for detection and study of mechanistic
neural processes are necessary to advance autism research in these settings. Eye tracking is a powerful, low-
cost, feasible neurobehavioral tool used in HIC for both autism detection and investigation of neurocognitive
processes. To achieve improved health outcomes in LMIC, a key research priority must include capacity building
in state-of-the science diagnostic and neurobehavioral methods for autism detection. The objective of this
proposal is to examine autism diagnostic outcome and eye-tracking markers in CHEU while building capacity for
neuro-health research in Kenya. We will accomplish this by leveraging a longitudinally assessed cohort of CHEU
and children who are HIV unexposed and uninfected (CHUU) with well characterized HIV-related and contextual
exposures (R01HD104552) and synergistically expanding our team’s ongoing neuro-health capacity building
efforts (R21MH127570). This work will be guided by a Community and Scientific Advisory Panel and situated
within the Academic Model Providing Access to Care (AMPATH) program. In Aim 1, we will compare autism
diagnostic outcomes between young CHEU and CHUU across a large cohort (N=850) of Kenyan children. In
Aim 2, we will determine whether neurobehavioral eye-tracking markers predict autism outcome in CHEU and
CHUU. Through a series of tiered training and mentorship activities integrated with the proposed research
activities of Aims 1 and 2, in Aim 3 we will build global scientific partnerships and upskill a Global Neuro-Health
Collaborative in Kenya with the clinical and research expertise, tools, and resources necessary to solve high
impact setting-specific health challenges. This study is innovative as it will be the first to apply rigorous diagnostic
and eye-tracking methodologies to investigate autism outcomes in CHEU in LMIC. The proposed work has high
potential to inform precision detection and intervention strategies to mitigate deleterious outcomes of both HIV
exposure and autism.

Public health relevance
PROJECT NARRATIVE The nearly 14 million African children who are HIV exposed but uninfected are at risk for poor health outcomes, including neurodevelopmental conditions such as autism; yet, there is a lack of expertise and diagnostic tools to carry out autism research in low- and middle-income countries. By leveraging a longitudinally assessed cohort of children, the proposed study will examine autism diagnostic outcome and eye-tracking markers in children who are HIV exposed and unexposed while building capacity for neuro-health research in Kenya. This study will be the first to rigorously examine autism outcomes in HIV exposed children and determine the validity of eye- tracking markers as a potential scalable diagnostic tool in resource-constrained settings, culminating in a Global Neuro-Health Collaborative well prepared to carry forward high impact transformative autism research in Kenya.